Proteomics

ABSTRACT: PROTEOMICS SHARED RESOURCE
The Proteomics SR (PROT) is a state-of-the-art facility that brings cutting edge proteomics research to LCCC
faculty. It is a well-established shared resource (SR) that provides consultation for the design of experiments,
sample preparation, mass spectrometry (MS) and extensive data analysis for LCCC members. Directed by an
expert staff, the SR is full service allowing users with projects but little experience to understand the range of
data acquisition opportunities. The SR also has the instrumentation that allows more experienced users access
to expensive, well maintained mass spectrometers. Core staff and expert users have extended the capabilities
with innovative techniques such as the MIB/MS analysis of cell wide kinase activity. Contributions include
validating and characterizing cancer-relevant drug targets, quantifying proteome and signaling network
changes in response to emerging therapeutics, studying the dynamic regulation of the kinome, describing how
specific pathways globally remodel cancer proteomes independent of changes in gene expression, and
determining how protein interaction networks are dysregulated in cancer.
Instrumentation includes; state-of-the-art mass spectrometers include: Thermo Lumos, Thermo QExactive HF-
X, Thermo QExactive Biopharma, Thermo QExactive HF, Thermo Orbitrap Velos and Sciex 5800
MALDI/TOF/TOF. All were partially purchased or leased by LCCC including four within the last four years. The
purchase and maintenance of the current PROT SR instruments are beyond the means of any individual lab.
LCCC investments have made it possible for multiple labs to access high end technology. The cost of PROT
SR services are generally lower by 25% than comparable private company or other academic institutions and
LCCC members receive an additional discount making the facility quite cost effective. The LCCC is requesting
$135,301 from the CCSG, which represents 21% of the total operating budget; 48% of the SR usage is by
LCCC faculty.